Transmission dynamics and fitness of reemerging St. Louis encephalitis virus in mosquito vectors and West Nile virus naïve and immune avian reservoirs

Project Summary/Abstract
The flavivirus St. Louis encephalitis virus (SLEV) infects humans to cause febrile illness and rare fatal
encephalitis. In California (CA), although human SLEV cases were detected from the 1940s-2003, none were
reported from 2004-2015. Since 2015, SLEV reemerged and spread to cause more cases in CA and the
Western US, including in areas with concurrent West Nile virus (WNV), a related flavivirus that invaded CA in
2003 that uses the same Culex vectors and avian hosts as SLEV. The reasons for the 11-year disappearance
of SLEV from CA and its expansion since 2015 are unclear. Spread of WNV across the US was facilitated by
augmented avian infection and enhanced vector competence but no studies have assessed host or vector
phenotype for reemerging SLEV. Our genetic tracing studies show that post-2015 (contemporary) SLEV in the
Western US likely originated in South America and is genetically distinct from pre-2003 (historic) SLEV. Our
experimental studies show that birds inoculated with historic SLEV one month after WNV inoculation, a time
when WNV neutralizing antibody titers are high, do not mount SLEV viremias, suggesting that SLEV after 2003
was displaced by extensive WNV avian herd immunity. Antibody-mediated neutralization is a hallmark of
protection from flavivirus viremia and disease and antibody therapies are used in severe human cases of WNV
and SLEV. Antibody is assumed to protect WNV immune birds from SLEV viremia and to prevent reinfection
from sequential SLEV>SLEV infection but has never been experimentally confirmed. Our preliminary data
show that serum from birds inoculated with historic WNV poorly neutralize some contemporary SLEV strains in
vitro. Reduced antibody mediated cross-neutralization of contemporary SLEV by contemporary WNV could
explain reemergence and persistence of SLEV in avian hosts. Augmented avian or mosquito infection may also
contribute to SLEV spread. We observe increased infectivity of reemerging SLEV isolated in successive years
since 2015 in duck embryonic fibroblast cells, but whether this pattern also manifests in avian reservoirs and in
mosquito vectors is not known. To understand drivers of reemergence, the goal of this project is to identify how
changing SLEV-vector-avian host interactions and cross-protection by WNV promote SLEV reemergence. This
will be accomplished via 3 project Aims: 1) Determine transmission competence and fitness of contemporary
versus historic SLEV in Culex, 2) Define avian fitness, antibody kinetics, and antibody-mediated protection for
contemporary versus historic SLEV, and 3) Evaluate avian cross-protection conferred by prior WNV for
contemporary versus historic SLEV. This project is significant in that it will define SLEV transmission dynamics
in the context of sequential invasion and concurrent spread of 2 Culex-borne flaviviruses endemic to the US.

Public health relevance
Project Narrative The avian-mosquito-avian cycling flavivirus St. Louis encephalitis virus (SLEV) that infects humans to cause febrile illness and rare fatal encephalitis has reemerged in the United States since 2015. To understand drivers of reemergence, this project will define infection and transmission dynamics of reemerging SLEV in mosquito and avian hosts and the role of antibody from prior SLEV or related West Nile virus infection in protection from viremia in avian hosts. This project is significant in that it will define SLEV transmission dynamics in the context of sequential invasion and concurrent spread of 2 Culex-borne human pathogenic flaviviruses endemic to the United States.